A culturally adapted decision aid intervention to support Chinese American dementia caregivers in feeding-related decisions

PROJECT SUMMARY
Family caregivers of people with dementia have to decide between tube feeding and hand feeding when
persistent eating problems arise. This decision can be difficult for Chinese-American dementia caregivers, due
to the interplay of culture, potential absence of a patient’s advance directive, poor understanding of dementia,
and lack of knowledge on the risks and benefits of tube feeding. There is a high prevalence of tube feeding
among Chinese older adults with advanced dementia; however, tube feeding does not have health benefits for
older adults with advanced dementia, and may in fact be related to increased risk and discomfort. Shared
decision-making is a process by which patients, family members, and healthcare providers work together to
create care plans that balance clinical evidence and patient preferences and values with risks and expected
outcomes. Current clinical discussions on feeding tubes rarely meet this standard. Limited research has been
conducted to improve decision quality regarding feeding options among Chinese-American dementia caregivers.
This pathway to Independence Award (K99/R00) will give Dr. Pei the training, mentoring, and skills necessary
to conduct intervention research to improve decision-making about feeding options for dementia patients in
Chinese American communities. The goal of this study is to develop and pilot test a culturally adapted decision
aid intervention to support Chinese American dementia caregivers in decision making about feeding options. To
become an independent investigator in improving end-of-life decision making, Dr. Pei will receive training and
mentoring in four areas: (1) deepening the knowledge of end-of-life decision-making, (2) gaining additional
training in qualitative methods research, (3) developing proficiency in clinical trial design and (4) enhancing
professional developmental skills in grant writing, research team management, and leadership. In the K99 phase,
the candidate proposes two aims. Aim 1: Conduct individual interviews with family caregivers and healthcare
professionals to inform the adaptation of an existing intervention; Aim 2: Develop, refine, and acceptability test
the culturally adapted decision aid. In the R00 phase, the candidate aims to refine and evaluate the efficacy of
the decision aid in a pilot randomized controlled trial among 60 Chinese American dementia caregivers (Aim 3).
By the end of the R00 award, Dr. Pei will complete the transition from observational and explanatory research to
behavioral intervention work and submit an R01 proposal. Her strong mentoring team, well-established
collaboration with community organizations in New York City, and ideal environment of research support and
resources at New York University will help Dr. Pei become a successful independent investigator in improving
end-of-life decision making for older adults with dementia.

Public health relevance
PROJECT NARRATIVE Although current clinical evidence suggests that the potential benefits of tube feeding do not exceed considerable associated treatment burdens in older adults with advanced dementia, rates of tube feeding remain disproportionally high among Chinese-American older adults with advanced dementia. This proposed project will culturally adapt an existing decision aid intervention to improve decision-making about feeding options for Chinese-American dementia patients. If effective, this intervention will indicate the utility of decision aids as a methodology with broader applications to decision-making in end-of-life care in this population.